Real-Time Monitoring and Scavenging of Reactive Oxygen Species (ROS) to Enhance Cochlear Implantation Outcomes

Project Summary
Hearing loss is the third most common health condition, affecting people of all ages. For individuals who are deaf
or have significant hearing loss, cochlear implants (CIs) are a standard treatment. CIs restore hearing by electrically
stimulating residual viable auditory nerve fibers in the cochlea with an implanted electrode array. However, cochlear
implantation is always accompanied by surgical injury, which initiates an acute inflammatory response to the
electrode and induces on-set and progressive loss of residual acoustic hearing. Thus, there is an urgent need to
develop a real-time monitoring method to help understand the neural conditions during and after implantation and
subsequent hearing loss to enhance post-operative clinical outcomes. Inflammatory process induces oxidative
stress (i.e. an elevated intracellular level of reactive oxygen species (ROS)) and reduces cellular antioxidant
capacity. Numerous studies have shown that oxidative stress plays key roles for chronic neuroinflammation.
Therefore, we hypothesize that oxidative stress is the major factor compromising CIs’ clinical outcome. In this R21
project, we propose to develop novel multifunctional CI electrodes and methods that can simultaneously monitor
and scavenge initiation of the oxidative stress pathway during and after cochlear implantation. We will develop the
multifunctional CIs to achieve real-time in vivo sensing and scavenging of ROS with clinically required sensitivity
and specificity. Our approach to develop advanced multifunctional CIs is to utilize the unique palladium (Pd) and
Pd bimetallic (i.e. Pd/Au) nanoparticles that show enzyme-like activities allowing sensitive and selective sensing of
ROS as well as converting ROS to neutral molecules. In contrast to existing surface technologies for auditory
neuronal protection and regeneration, our noble metal nanocatalysts as CIs electrodes are corrosion-resistant and
biocompatible, and their unique surface electrochemistry can provide continuous (during and post-operative times)
sensing and removal of ROS in vivo with high stability. The simultaneous neutralization of ROS with their
electrochemical sensing reactions should mitigate oxidative stress-related cell death without disrupting the well-
integrated innate antioxidant defense network, thus, improving post-operative clinical outcomes for individuals with
CIs. In Aim 1, we will design and fabricate multifunctional CIs with bimetallic Pd/Au nanocatalysts integrated into a
flexible parylene-based electrode array for detecting and scavenging ROS in vitro. In Aim 2, we will validate the
detection and scavenging functions of the multifunctional CIs with an integrated microchannel in a rat model. Results
from these pre-clinical development and validation studies in this R21 project will form the basis of a long-term R01
project to fully integrate sensing/scavenging capability into CI devices that are capable of recording, stimulation,
sensing and scavenging functions for long-term clinical use. We also foresee the opportunities to apply the results
gained here to other neural interfaces and medical implants. Our established multidisciplinary team with each
member has more than 20 years’ experience with in vivo neuroprobe, real-time chemical sensor technology, and
auditory neurophysiology respectively, making us well prepared to be successful in the proposed research activities.

Public health relevance
Project Narrative Cochlear Implants (CIs) are considered a standard treatment for children and adults who are deaf or severely hard-of-hearing, but surgical implantation of the CI electrodes is traumatic, and often leads to further loss of residual acoustic hearing. Numerous studies show that oxidative stress (i.e. an increase of reactive oxygen species (ROS)) plays key roles in the post-implantation trauma and subsequent hearing loss, and the mechanisms by which ROS are generated and metabolized are not well understood because there are no available methods to measure them reliably and accurately in situ in current CI electrodes. The goals of this project are to develop an in situ real-time multifunctional CI electrodes to measure ROS in the cochlea, to study the relationship between oxidative stress, implantation trauma, and the hearing loss, and to scavenge or neutralize ROS as they are generated and detected, ultimately preventing additional hearing loss and enhancing post-operative clinical outcomes for cochlear Implantees.